Discipline: A - Track: Three

Project Summary DA/T3 Animal Food Product Testing The purpose of this analytical track is to improve food testing surveillance programs through the microbiological analysis of food products. The test results generated by these laboratories can be used to remove adulterated food from commerce and aide regulatory inspection programs in conducting investigations. WI BLS is proposing to test raw pet foods both produced and sold in the state of Wisconsin. The raw pet food industry has been growing significantly over the past decade, and our programmatic Division, the Division of Agrichemical Management (DARM), has been discussing the idea of testing these products for some time. However, due to cost constraints, this project has not been moved forward, and was unlikely to be any time soon. Since DARM has no information on these products, they would like to test at least 100 samples each year for the next 5 years, for E. coli STEC, Salmonella, and Listeria. Based on the data provided over the next 5 years DARM may develop a monitor program for this commodity. This project will not only provide DARM with information it can use to develop a monitoring program, it also helps protect the people of the state of Wisconsin. Further, it provides the FDA with the data it is in search of to help develop and strengthen the food supply for animal, and prevent foodborne illnesses in humans.